Live-Cell Chromatin Imaging and Biology: Application to Extrachromosomal DNA

PROJECT SUMMARY
Genome regulation is the prime mechanism that governs the precise spatiotemporal gene expression program
that, in turn, establishes and maintains the cellular states in tissues and organs in multicellular organisms. In
humans, genomic changes that alter this regulation can cause a wide range of diseases such as cancer.
Demystifying genome regulation has become a central task of modern biology in the post-genomic era and is
the foundation for effective disease management and promotion of health. Homeostatic genome regulation
ensures precise spatiotemporal chromosomal gene regulation in properly insulated chromatin structures, in the
cis-configuration (same chromosome), and through faithful symmetric segregation during mitosis. In stark
contrast, these rules are broken in human cancers particularly in the form of extrachromosomal DNA (ecDNA)
that enables insulation crossover, trans regulation, and asymmetric inheritance. Named as a 2021 Cancer Grand
Challenge by the National Cancer Institute, megabase-sized circular ecDNA typically contains common
oncogenes and regulatory elements present in major human cancer types, driving massive oncogene
amplification and expression, enabling intra-tumoral heterogeneity, and conferring drug resistance and poor
patient survival. The fundamental molecular mechanisms governing ecDNA expression, interaction, and
propagation are largely unknown. Although powerful biochemical, genetic, and genomic approaches have laid
the conceptual framework of modern understanding of genome regulation, the largely population-based, time-
averaged, and sometimes out-of-context measurements are insufficient to fully describe the spatially
compartmentalized, temporally dynamic, and physiologically relevant higher-order interactions in single live cells.
The fundamental challenges stem from lack of chromatin tools to label the intrinsically heterogeneous chromatin,
limited spatiotemporal resolution to monitor the highly concentrated and dynamic molecular transactions, and
the paucity of quantitative and rigorous methods to extract fundamental physical rules underlying genome
regulatory processes. In this project, we plan to overcome these primitive challenges by initiating a radically
distinctive technological development of robust, efficient, and multiplexable chromatin labeling strategies for live-
cell chromatin biology, which will allow us to apply them to address the fundamental regulation of ecDNA in the
cancer genome. We will integrate advanced imaging, cutting-edge microscopy, modern synthetic genome
engineering, and optical/genetic perturbation to systematically study the basic mechanisms by which ecDNA
orchestrates massive oncogene transcription, extensive chromosomal remodeling, and asymmetric segregation
hitherto intractable by conventional biochemical, genetic, or genomic methods. Positive outcome of these cutting-
edge approaches and high-risk high-reward questions embedded in our proposal will have a transformative
impact on mechanistic dissection of cancer genome regulation and may help us to uncover an Achilles' heel with
which to target ecDNA-driven cancer, thereby affording wide-ranging positive influence on human health.

Public health relevance
PROJECT NARRATIVE Extrachromosomal DNA (ecDNA) represents a new cancer hallmark and Cancer Grand Challenge as we currently lack experimental tools and quantitative methods by which to dissect mechanisms of ecDNA regulation in the cancer genome at a single cell level. In this project, we will develop innovative live-cell chromatin visualization, manipulation, and profiling tools, which will allow us to probe the fundamental rules of cancer ecDNA regulation. Understanding these fundamental ecDNA regulatory principles is essential to design novel strategies aimed at improving the treatment of ecDNA-associated cancer.